Measurement and characterization of CNS and immune tissue myeloid HIV-1 reservoirs

Long-lived cells latently infected with HIV-1 form a viral reservoir that cannot be eliminated by current
anti-retroviral therapy regimens, even when those therapies are applied over an infected person's lifespan. A
comprehensive understanding of cellular and tissue-based reservoirs would facilitate the development of new
approaches to eradicate this persistent viral reservoir.
We hypothesize that brain and immune tissue macrophage-lineage cells constitute a significant HIV-1
reservoir that is genetically and phenotypically distinct from the CD4+ T cell reservoir. Highly sensitive methods
will be used to quantify HIV-1 nucleic acids present in macrophage lineage cells in brain, CSF, and immune
tissue and to also determine whether astroglia contribute to a non-T cell reservoir. A key issue is whether
macrophage-lineage cells are actually infected, or whether detectable HIV-1 nucleic acids represent ingested
or contaminating T cells. Using highly purified macrophages, we will ascertain whether they carry full length,
intact proviruses, actively express HIV-1 mRNA, and can produce infectious virus. We will also establish
whether macrophage proviruses can be activated ex vivo by latency reversing agents (LRAs).
Finally, we will use PacBio next generation sequencing (NGS) and single genome analyses (SGA) to
investigate phylogenetic relationships and compartmentalization of HIV-1 in brain, CSF, and immune tissues
and in specific cell types i.e. purified macrophages, astroglia and T cells. We propose the following three aims:
Aim 1. To measure and characterize the HIV-1 reservoir in macrophages from brain and immune tissue. HIV-1
proviral DNA and mRNA will be quantified in macrophage-lineage cells and T cells purified from brain, CSF,
and immune tissue to better understand the number and distribution of cells that are infected and expressing
HIV-1 mRNA.
Aim 2. To evaluate the presence of replication competent HIV-1 in macrophages from brain and immune
tissue. PCR and culture protocols will evaluate whether intact, integrated, replication-competent proviruses are
present in macrophages and can be activated with LRAs.
Aim 3. To investigate the phylogenetic relationships of HIV-1 in macrophages and T cells in brain and immune
tissue. Single genome PCR and PacBio deep sequencing of env and pol genes will be used to investigate the
relationships between HIV-1 found in macrophages and T cells in brain, CSF, and immune tissue.
Our proposal aims to (1) determine whether macrophages in immune tissue are infected with HIV-1 and
form a viral reservoir, (2) set up approaches to quantify infectious HIV-1 proviruses in monocyte/ macrophages
in brain, CSF and immune tissue and (3) establish phylogenetic relationships between HIV-1 populations
present in purified macrophages and T-cells present in different tissues. Study results will be important for
informing strategies to achieve remission, and potential cure, in HIV-1 infected individuals.

Public health relevance
This work will examine the extent to which HIV infects different cells in the brain and immune tissue. Genetic sequences and biologic properties of viruses from brain and immune tissues of HIV-infected individuals with and without clinical neurologic findings will be examined and compared. Study results will be important for improving approaches to reduce neurologic side effects and to achieve remission, in HIV-1 infected individuals.